Pluripotent stem cell modeling to identify gene/environment influences on placental angiogenesis and severe fetal growth restriction

PROJECT SUMMARY/ABSTRACT
Fetal growth restriction (FGR) is the second-leading cause of perinatal morbidity and mortality. Severe cases,
especially those with placental vascular changes reflected by absent or reversed umbilical artery Doppler
velocimetry (FGRa/r) on ultrasound, are at high risk for perinatal death and exhibit substantially worse outcomes
than FGR with preserved fetoplacental blood flow, suggesting that this flow is vital to fetal well-being. The only
management option currently is delivery, with guidelines suggesting delivery no later than 34 weeks despite
concomitant risks of prematurity.
One consistent finding in FGRa/r is inadequate development of placental vessels through the latter half of
pregnancy. This sparse vasculature compromises fetal oxygen and nutrient extraction from the maternal
intervillous space, giving rise to hypoxia and acidosis, while simultaneously increasing fetal cardiac afterload.
Based on a strong correlation between FGRa/r and maternal vascular malperfusion (MVM) – a histopathologic
pattern representing placental injury due to defective deep placentation, inadequate uterine vascular remodeling,
consequent aberrant intervillous blood flow, and hypoxia-reperfusion (H/R) injury – the conventional view is that
FGRa/r is the product H/R injury. However, up to 50% of pregnancies with uncomplicated outcomes also exhibit
MVM. Thus, how placental angiogenic deficiencies arise, whether they are solely a consequence of early insults
resulting in H/R injury, and how fetal genetic susceptibility to in utero events impacts placental angiogenesis
remain major gaps in knowledge.
To address these concerns, this R21 application proposes to leverage induced pluripotent stem cell (iPSC)
technology and its capacity to abrogate donor transcriptional, epigenetic, and functional signatures. Starting with
control (C) and FGRa/r (F) cohorts that display MVM as an indicator of H/R exposure, we will isolate placental
stromal fibroblasts (FBs), reprogram them into iPSCs, followed by differentiation into endothelial cells (iPSC-
ECs). These iPSC-ECs represent placental ECs naïve to prior in utero exposures while retaining donor genome.
By comparing methylomic, transcriptomic, and functional signatures between iPSC-ECs and their subject-
matched, primarily isolated FBs and placental ECs, we will be able to rigorously characterize C- and F-iPSC-
ECs (Aim #1) and examine the interplay between gene and environment in FGRa/r pathogenesis (Aim #2).
Completion of proposed aims will provide critical foundation for (1) identifying targets that promote placental
angiogenesis in spite of early in utero insults, thereby increasing surface area for maternal-fetal exchange and
improving fetal cardiac function, and (2) generating patient-specific, clinically relevant models with which to test
potential therapies.

Public health relevance
PROJECT NARRATIVE Fetal growth restriction (FGR) is the second-leading cause of perinatal morbidity and mortality, and severe cases with abnormal placental blood flow exhibit substantially worse outcomes than FGR with normal placental blood flow. This proposal seeks to develop a novel model to delineate genetic and environmental contributors to severe, early-onset growth restriction. The knowledge gained from completion of this project will provide critical foundation for identifying targets that promote placental vessel growth in spite of early in utero insults and for development of patient-specific, clinically relevant models with which to test potential preventative and therapeutic strategies.